"Core B" Viral RNA-seq and bioinformatics Core

Summary
Computational biology is becoming increasingly integral to biological science research as relentless
technological advances increase the capabilities and depth of data that is put at arm’s reach of investigators.
Computational biology and bioinformatics resources are even more critical for the RNA-centric goals of this P01.
In the previous project period, Core B worked to provide effective and timely computational biology and
bioinformatics services to P01 investigators, resulting in 11 Core B-associated publications. In addition to Core
B working to improve capabilities and efficiency, it provided custom analysis software for project-specific needs,
and provided computational biology and bioinformatics training to junior P01 investigators. Specifically, Core B
reduced data processing times of standard analysis pipelines for RNA-seq, ATAC-seq, and ChIP-seq through
the development of automated comprehensive analysis software that operates on the Tulane University and
University of Florida High Performance Computer (HPC) clusters. These pipelines substantially cut primary data-
to-interpretation times, and their comprehensive nature provides high value to P01 personnel. The automated
nature of these pipelines also reduces Core B personnel operation time, allowing them to dedicate more effort
to other tasks, such as development of new computational methods and teaching. During the previous project
period, Core B also developed more than 7 software packages in direct response to the needs of Projects 1, 2
and 3. Lastly, Core B utilized a multipronged approach to train junior P01 investigators, arming them with
powerful computer programming and data analysis skills that will help them take advantage of the growing
importance of computational biology and bioinformatics in biomedical science. In the next project period, Core B
will continue to provide rapid and comprehensive services to P01 investigators, increase the efficiency and
capabilities of Core B, develop new software packages to meet the needs of Projects 1, 2, and 3, and continue
to train the next generation of gammaherpesvirologists in computational biology and bioinformatics.

Public health relevance
Project Narrative In the next project period, Core B will provide computational biology and bioinformatics services to Projects 1, 2, and 3. Core B will also develop new comprehensive next generation sequencing analysis pipelines to expedite data-to-interpretation times for P01 investigators, develop new project-specific software for Projects 1, 2, and 3, and continue training junior P01 investigators in computational biology and bioinformatics.